Relevance of Abeta N-terminal Truncations for Alzheimer Pathogenesis and Therapy - Resubmission - 1

Impaired brain clearance and abnormal Aβ degradation are considered key events for the formation and progressive accumulation of soluble neurotoxic oligomers and the development synaptic pathology, one of the strongest correlates to cognitive impairment. Clearance studies mostly centered in monomeric Aβ40 have provided a basic assessment of the participating mechanisms but the complex molecular and structural heterogeneity of the brain Aβ peptidome has been largely overlooked. The most obvious heterogeneity resides in the multiple N- and C-terminal truncated fragments that populate the Aβ peptidome; surprisingly, little is known about their homeostasis or their potential contribution to disease pathogenesis. Our studies indicate that while C-terminal truncations increase solubility and abrogate oligomerization/fibrillogenesis, properties associated with clearance mechanisms, N-terminal truncations, particularly Aβ4-x, exhibit enhanced pro-amyloidogenic and neurotoxic characteristics in vitro and in vivo, being particularly abundant in parenchymal deposits in AD and multiple APP Tg models and requiring detergents/formic acid for tissue extraction. Proteomic studies of tissue deposits and novel antibodies specific for the free N-terminus of Aβ4-x showed their topographic association with fibrillar plaque cores. Notably, these antibodies prevented Aβ4-x oligomerization, abrogated toxicity, and rescued behavioral deficits in a passive immunization pilot study. We hypothesize that N-terminal truncation of Aβ at position 4 generates pro-amyloidogenic fragments that progressively accumulate in brain deposits as a result of their high oligomerization propensity, poor brain removal, and resistance to proteolytic degradation, perpetuating the amyloidogenic loop, and postulate that passive immunization constitute a feasible therapeutic approach to reduce formation of Aβ4-x toxic oligomers and fibrillar deposits, restoring synaptic function and improving cognitive parameters. We propose to compare Aβ4-x clearance mechanisms with those of full-length Aβ40/Aβ42 in WT mice, assessing involvement of Aβ efflux transporters LRP-1 and P-gp and how brain efflux is influenced by oligomerization, local proteolytic degradation, and aging (Aim 1). The temporal accruement of Aβ4-x species as the disease establishes and progresses will be evaluated by proteomic analysis of the brain Aβ peptidome in APPswe/PS1ΔE9 and 3xTg of different age as well as in human specimens from MCI, mild, and severe AD. Intracerebral inoculation of AD-isolated Aβ4-x species will be used to evaluate seeding capabilities in young Tgs (Aim 2). Preventive and therapeutic benefits of MAb anti-Aβ4-x will be tested in passive immunization protocols in the same Tg models, assessing changes in behavioral parameters, biochemical composition of the brain Aβ peptidome, type and distribution of parenchymal Aβ lesions and ratio Aβ4-x to Aβ40/42. Cognitive changes will be correlated with the preservation/rescue of synaptic markers, electrophysiological parameters, and metabolic / bioenergetic features in isolated synaptosomes, all elements directly linked to synaptic function (Aim 3)

Public health relevance
Understanding the molecular basis that regulate the delicate balance among Aβ production, its dynamics of aggregation and rate of clearance is a crucial step towards the identification of brain homeostatic mechanisms that modulate the undesirable formation of neurotoxic oligomers and an alternative path in the search for new targets of therapeutic interventions. Our proposal centers in the often-neglected heterogeneity of the brain Aβ peptidome – going well beyond the classic Aβ40/Aβ42 dichotomy – by focusing specifically in the brain clearance mechanisms and seeding potential of the pro-amyloidogenic and neurotoxic Aβ4-x species and their contribution to the synaptic dysfunction and cognitive impairment characteristic of Alzheimer's disease. A translational approach using antibodies highly specific for the Aβ4-x species in passive immunization protocols provides additional proof-of-concept to the contribution of these fragments to the disease pathogenesis while unveiling a not previously recognized novel therapeutic target.